Elucidating the structural basis of mitochondrial outer membrane permeabilization in apoptosis

Abstract
Mitochondrial apoptosis is a stress-triggered cell death pathway implicated in health and disease. This
pathway is readily blocked in cancer. Mitochondrial poration is at the heart of mitochondrial apoptosis being
regulated by the BCL-2 proteins. This process regulates the release from mitochondria of prodeath factors that
activate the caspase cascade which dismantles apoptotic cells. Mitochondrial poration is executed by the
BCL-2 protein BAK. Here we propose to delineate the mechanism of mitochondrial poration by BAK, which is
elusively defined and controversial. In particular, we propose to elucidate 1) the mechanism of BAK activation,
2) BAK association with and poration of membranes, and 3) BAK recognition and sequestration by prosurvival
BCL-2 proteins. To accomplish these aims we will use a multi-pronged approach including high-resolution
structural biology, biophysics, biochemistry, and cell biology to generate a complete picture of mitochondrial
poration by BAK. Upon successful completion we will redefine our mechanistic understanding of this process,
and we will reveal innovative ways to target apoptosis in pathophysiology.

Public health relevance
Mitochondrial poration by the BCL-2 protein BAK initiates apoptosis yet it remains poorly characterized and controversial. We will redefine the mechanistic understanding of mitochondrial poration by delineating how BAK is activated, how it associates with and porates mitochondria, and how it is recognized and blocked by prosurvival BCL-2 proteins.